Population, Life Course and Aging

Abstract
We propose to continue, expand, and improve the NIA training program in the demography of health and aging located in
the Center for Demography of Health and Aging (CDHA) at the University of Wisconsin-Madison (UW). We request
support for 4 predoctoral and 1 postdoctoral positions, a level equal to our current trainees for the period 2012-2017. This
support is essential for sustaining a critical mass of trainees and training-related research activity and supporting efforts to
broaden our training activities. The NIA training program on health and aging builds on the resources of the Center for
Demography of Health and Aging (CDHA) and works collaboratively with the Center for Demography and Ecology
(CDE) to form a long-standing, highly-visible core of demographic research and training at UW. The program benefits
from the interdisciplinary integration of research and teaching across the Departments of Sociology, Economics, and
Population Health Sciences, as well as the Institute on Aging, the Institute for Research on Poverty, the La Follette School
of Public Affairs, and other research centers and training programs at UW. The NIA training program has trained and
placed productive and innovative predoctoral and postdoctoral trainees who are contributing substantially to research,
training, and public service in the demography of health and aging.

Public health relevance
Public Health Relevance The Center for Demography of Health and Aging at the University of Wisconsin-Madison offers outstanding and innovative training in the demography of health and aging, enriched by training and research opportunities involving biological models of health and aging. Our trainees predominately enter research careers in academic and government institutions and agencies. Their research increases the understanding of basic behavioral processes related to health and aging and influences national policies that affect the health and well-being of all groups of the American population.